Functional genomics of the dynamic molecular network controlling mRNA translation and decay

ABSTRACT
Cells respond to environmental changes and stresses by modulating the translation and decay
of mRNAs in the cytosol. This post-transcriptional regulation is critical for maintaining proper
cellular physiology. Often, these regulatory programs protect cells from pathological stresses. In
other cases, however, maladaptive responses underlie disease phenotypes. Understanding
these dynamic, environmentally responsive post-transcriptional regulatory programs is critical
for understanding cell physiology and promises novel therapeutic targets to support protective
responses and suppress damaging ones.
Recent work has catalogued hundreds of mRNA-binding proteins. Our understanding of how
these proteins affect the mRNAs they bind has lagged behind studies that enumerate these
proteins, and we generally lack an understanding of their broader role in the cell. Our motivating
hypothesis is that many of these proteins target speciﬁc transcripts and regulate their translation
and stability in a coordinated fashion in response to environmental and intracellular cues.
Indeed, we know of regulatory proteins that bind transcripts encoding functionally related genes
and switch between promoting decay or promoting translation in response to regulatory
phosphorylation. We believe that this represents a more widespread model.
The broad scientiﬁc goal of this proposal is to elucidate the functional networks of post-
transcriptional regulation in the cell. We will apply high-throughput and unbiased approaches to
work outward from mRNA-binding proteins in order to identify the signals that control their
activity, the upstream and downstream factors that mediate their effect, and the regulatory
programs that they control. Our work will reveal the general principles governing how and why
gene expression is controlled post-transcriptionally. We will also develop approaches that can
be transferred to address this question in a wide array of other biological systems.

Public health relevance
NARRATIVE Cells switch genes on and off in response to changes in their environment and signals from neighboring cells. We propose to map out the network of regulators in the cell that is responsible for one layer of control over gene expression. By learning how and why cells control genes in this way, we will better understand how healthy cells resist stresses and how these results go awry in disease.